ASSESSMENT OF HYDROGEN PEROXIDE GENERATION IN NEUTROPHILS BY FLOW CYTOMETRY

Develop and apply an assay for evaluating hydrogen peroxide production by human neutrophils following stimulation using flow cytometry. Apply this technique to patients with CGD and the X-linked obligate carriers. in addition, optimize the assay in an attempt to Improve the detection sensitivity.